Using partners to enhance long-term weight loss

Abstract
Obesity is the second leading cause of preventable deaths in the United States. Weight loss, and maintenance
of weight loss, improves cardiovascular disease risk factors, physical functioning, and quality of life.
Interventions that combine dietary change, physical activity increase, and behavioral strategies are efficacious
for short-term weight loss but less so for long-term weight loss. Given that the best predictor of long-term
weight loss is initial weight loss, strategies are needed to enhance both initial weight loss and weight loss
maintenance. Dietary and physical activity behaviors often are influenced by domestic partners. Therefore,
intervening jointly on patients and their partners is likely to improve the efficacy of weight management
programs. This study involves an evaluation of the role of domestic partner support in a comprehensive weight
loss initiation and maintenance program. Eligibility criteria include age 18-75, BMI ≥27 kg/m2 with an obesity-
related comorbidity or BMI ≥30 kg/m2, and cohabitating with a domestic partner. 230 couples will be
randomized to 18-month comprehensive weight program directed at patients alone or involving their partners.
In months 1-6, all patients will receive group-based weight loss program featuring a calorie-restricted diet and
physical activity. In months 7-18, all patients will receive a weight loss maintenance intervention that involves
maintenance-specific content, transitions to individual telephone calls, and gradually decreases in frequency of
contact. In the partner-assisted arm, partners will learn and practice communication skills and support
strategies to facilitate patient health behavior change. Partners will attend patient group sessions, be informed
of patients' goals (during initiation) and relapse plans (during maintenance), and receive reinforcing text
messages. In months 19-24, intervention will be withdrawn to examine sustainability of effects. Our primary
hypothesis is that average 24-month weight in the partner-assisted intervention will be at least 2.5 kg lower
than in the patient-only intervention. Secondary outcomes include caloric intake and physical activity at 24
months. Mediation analyses will examine the role of interdependence theory constructs and social support. If
successful, this approach could inform refinement and implementation of effective obesity treatments.

Public health relevance
Project Narrative Domestic partners are a readily available and potentially powerful source of support for people trying to make lifestyle changes. The proposed study will examine long-term weight loss could be improved by teaching partners how to provide meaningful, constructive support. If so, involving partners in weight management programs could help patients to better manage their weight, increase their quality of life, and improve their health.